Using Smartphone Assessments for Personalized Prediction of Problematic Alcohol Use

PROJECT SUMMARY/ABSTRACT
Risky drinking, such as binge (5+/4+ drinks per 2-hour occasion for males/females) and high-intensity (2-3x
the rates of binge) drinking, is highly prevalent among young adults and associated with severe acute and
longer-term negative behavioral and health outcomes. However, given its prevalence, individuals who engage
in such activities comprise a heterogeneous group. Researchers have had a hard time identifying the varied
behavioral processes that are predictive of negative alcohol-related consequences and problematic trajectories
across time. Predicting who will go on to develop lasting problems and whose risky alcohol use behavior is
developmentally-limited is especially challenging. Part of the hindrance comes from the methods that are
currently used to study this diverse behavior. In particular, researchers often use cross-sectional studies to
look across individuals. While this has reaped invaluable knowledge regarding differences among individuals in
their drinking patterns, it does not reveal the dynamic processes that contribute to maintaining such behaviors
or make one more likely to have negative consequences. However, increasingly hypotheses pertain to these
dynamic processes. This requires arriving at quantitative descriptions of individuals' emotional and behavioral
processes. The science can move towards a more nuanced understanding of the varied
mechanisms contributing to problematic alcohol use by arriving at valid descriptions of
individual-level (i.e., personalized) processes.
We propose to make advances towards personalized quantitative models in four ways: 1) develop an informed
intensive longitudinal research design that enables acquisition of relevant variables across time on a daily basis
and across the span of one year; 2) use innovative measurement technologies that enable objective assessment
of contextual features related to drinking; 3) collect data using state-of-the-art phone applications that enable
self-report and passive data collection where the user does not need to interface; and 4) implement cutting-
edge machine learning algorithms that can reliably arrive at individual-level detection and predictive models
that can be used as the foundation for future just-in-time adaptive interventions. We will accomplish this by
enrolling N=300 young adult risky drinkers who will complete a 120-day ambulatory assessment protocol
completing surveys on smartphones that are also equipped with passive sensors and applications, and then
provide 4 waves of data on alcohol use and associated variables (e.g., consequences) over one year.
In the end, our endeavors will create novel approaches to measuring and modeling behavioral processes related
to high-risk drinking that capture the individuality of each participant. These endeavors will provide the
framework for accurate detection and prediction of daily drinking and long-term problematic alcohol use
trajectories that support future scientific and clinical efforts.

Public health relevance
PROJECT NARRATIVE Risky drinking behavior (i.e., episodic binge and high-intensity drinking), which peaks in young adulthood, is estimated to account for more than 40,000 deaths annually and over $167 Billion in economic costs in the United States. Young adult risky drinkers are a heterogeneous group, which makes them very difficult to study and to predict who will go on to develop lasting problems with alcohol use and alcohol use disorder. This research will implement cutting-edge machine learning techniques, and apply them to data collected from daily surveys and passive smartphone sensors in young adult risky drinkers to develop personalized models of problematic alcohol use.